Symptomatic Toxicities & Quality of Life among Diverse Individuals Receiving Immune Checkpoint Inhibitors for Metastatic Cancer.

PROJECT SUMMARY
Immunotherapy has revolutionized cancer treatment and has become the fourth pillar of cancer care alongside
surgery, radiation, and chemotherapy. Immune checkpoint inhibitors work by binding to proteins in order to
enable the immune system to recognize and attack cancer cells. Although checkpoint inhibitors offer patients
with metastatic solid tumors new options for effective, life-prolonging care, treatment can be accompanied by a
host of mild to moderate toxicities and, in some cases, severe or life- threatening immunotherapy-related adverse
events (irAES) that cause significant decrements to health-related quality of life (HRQoL). Toxicities vary by ICI
class, up to 95% of patients experience at least one toxicity of any grade and between 10% to 47% experience
at least one severe (grade 3 or 4) toxicity. Serious irAES like hepatitis, pneumonitis, colitis, and other autoimmune
reactions may require immediate management or hospitalization. Toxicities may occur shortly after treatment or
emerge as late effects months after treatment. Despite the serious and debilitating consequences of clinician-
reported toxicities, limited work has captured patients’ experience on checkpoint inhibitors using patient-reported
outcomes (PROs) or identified multilevel predictors and clinical endpoints of symptomatic toxicities and HRQoL
in a well-characterized sample of racially, ethnically, and socioeconomically diverse patients. Therefore, the aims
of this study are to: Aim 1a) characterize toxicities and HRQoL over time among diverse individuals receiving
checkpoint inhibitors for metastatic cancer (N=416) and Aim1b) examine associations with sociodemographic
and medical characteristics to identify patient profiles who are at elevated risk for toxicities and decrements in
HRQoL; Aim 2) examine potentially modifiable behavioral, psychosocial, and care delivery factors that account
for associations between sociodemographic/medical characteristics and toxicities and HRQoL to inform targets
of future intervention; Aim 3) examine whether toxicities and HRQoL predict clinical endpoints, including ICI
modification, discontinuation, or reinitiation, clinician-reported irAES, cancer progression, death, and healthcare
utilization (hospitalization, ED visits, use of oncology nurse triage line). Furthermore, we will use cutting-edge
machine learning methods as the basis to create a nomogram prediction tool– the first of its kind that (with future
validation) will allow clinicians and patients to estimate a patient’s risk of toxicities and related endpoints using
PROs. With our history of successful collaboration, robust immunotherapy programs, and notably diverse
catchment areas, the University of Miami Sylvester Comprehensive Cancer Center and UT Health San Antonio
Mays Cancer Center are uniquely positioned to conduct this research. In alignment with NCI Moonshot Initiative
priorities, this research will generate crucial knowledge to inform intervention efforts to equitably improve the
safety and tolerability of checkpoint inhibitors and prevent and mitigate toxicities among diverse patients.

Public health relevance
NARRATIVE The goal of this study is to prospectively characterize toxicities and health-related quality of life (HRQoL) among diverse individuals with metastatic cancer who are initiating immune checkpoint inhibitors and identify multilevel predictors and clinical endpoints of toxicities and HRQoL over a 2 year follow-up period. In alignment with NCI Moonshot Initiative priorities, this research will generate crucial knowledge to inform future intervention efforts to equitably improve the safety and tolerability of checkpoint inhibitors and prevent and mitigate toxicities.